Spinning Disk Confocal Microscope System

Project Summary/Abstract
Our NIH user group from an Emerging Research Institution requests funds from the NIH BIG program to
purchase a Nikon CSU-W1 spinning disk confocal microscope system to be housed at Providence College
(PC) in Providence, RI. This acquisition is essential to our NIH-funded investigators who require high-
resolution 3D fluorescence microscopy for their projects. Currently, most of our investigators rely on a 14-year-
old Zeiss LSM 700 confocal microscope system that is experiencing hardware breakages and software
crashes related to its age, and the system has been discontinued from service by Zeiss. This system has
major imaging issues including weak laser power, low sensitivity, slow scan speed, photobleaching, and
phototoxicity. These issues are damaging to our research programs and limit our ability to perform our
NIH-funded research projects. PC has recently completed massive renovations costing over $55 million
dollars to create a state-of-the-art Science Complex. Part of this renovation included building a brand-new
Microscope and Imaging Facility. The expansion of the Science Complex has been accompanied by the
recruitment of new faculty with diverse biomedical research projects with distinct confocal imaging needs.
We have a significant need for an upgraded confocal imaging system like the CSU-W1 that allows for
diverse imaging applications, including 3D imaging of live or/and fixed cells and tissues. The Nikon CSU-W1
spinning disk confocal is a high-speed, high-resolution imaging system featuring an ultra-wide field of view and
enhanced signal-to-noise ratio. The CSU-W1 has a wider inter-pinhole spacing in the spinning disk that
reduces pinhole crosstalk allowing deep imaging applications from 50 to 100um. Our CSU-W1 will be
equipped with five CFI Plan Apo objectives (4x, 20x, 40x, 60x oil, and 100x oil) and four laser lines (405, 488,
561, and 640nm) that will meet the needs of all users. The Ti2-E inverted microscope base is fully motorized,
with a stable, drift-free platform. The Prime BSI Express CMOS camera (2048x2048) has a near perfect 95%
quantum efficiency to maximize signal detection. The CSU-W1 also includes a workstation equipped with
NIS-elements AR software that allows control of the CSU-W1 imaging system and has built-in multi-X, Y, Z,
Time, multichannel experiment capabilities. This instrument allows time-lapse imaging of live cells without
complications of phototoxicity, image stitching of large tissue sections, fast acquisition of 3D volumetric multi-
channel images, and high-resolution imaging to view fine structures in cells. These features will be used
for diverse biomedical research projects to identify structural changes in neurons associated with disease
and behavior, cell size and cell division mechanics, host-pathogen interactions, transport processes in squid
photoreceptors, cellular effects induced by novel small molecule probes, and signaling pathways induced
by microneedles in human skin. This user group has an immediate need for the CSU-W1 spinning disk
confocal to support current projects and to expand and innovate their biomedical research programs.

Public health relevance
Project Narrative Providence College has recently completed massive renovations to create a state-of-the-art Science Complex that has been accompanied by the recruitment of new faculty with diverse biomedical research expertise. There is increased demand for a confocal microscope that allows for diverse imaging applications, including 3D imaging of live or/and fixed cells and tissues, which is why we are submitting this proposal for a Nikon CSU-W1 spinning disk confocal. All of our NIH-funded investigators have a significant need for the CSU-W1, not only to support their current projects, but to expand and innovate their biomedical research aimed to identify the cell and molecular mechanisms involved in brain disease, cognitive behavior, cell size control, cell division assembly, motor protein transport, host-pathogen interactions, skin cell rejuvenation by microneedles, and the biological effects of novel small molecule probes.